Bioethics of Archival Human Temporal Bone Collections

Project Summary
In researching the history of the archival human temporal bone histology slide collection at Johns Hopkins
procured in the early through mid 1900s, several questions arose regarding the history and ethics of the
consenting process for obtaining postmortem temporal bone specimens during periods with less sophisticated
practices than today's standards. Additionally, our collection includes an over-representation of certain groups
of historically marginalized patients who may have been subject to disparate living conditions, structural
inequities, and medical treatment. We will consider the historical, environmental, geographical, social, and
economic factors that may have contributed to disparate treatment of non-white individuals, women, individuals
with disabilities (in particular, hearing and balance disorders), economically disadvantaged individuals,
immigrants, children, and the elderly in medical settings, and, consequently, may have rendered these
individuals more likely to have been subject to death, postmortem autopsy, and temporal bone harvest. Prior to
making images of these slides accessible to researchers outside our group, we will perform a thorough
assessment of these ethical considerations and develop guidelines for the future use of archival human temporal
bone histology specimens in research. Our specific aims are to 1) perform a systematic retrospective analysis
of the history and ethics of consent for human temporal bone donation and procurement in the 1900s, and 2)
develop a community advisory board to inform decisions regarding the future use of the Johns Hopkins temporal
bone histology slide collection and future temporal bone harvest and data-sharing. To ensure that our work is
informed by diverse perspectives, we will include researchers from historically marginalized groups (individuals
who identify as women, non-white, immigrants, deaf/hard of hearing) in the bioethics research process, including
both co-investigators and trainees. We plan to engage community representatives to ensure that human
temporal bone research is performed in an ethical, inclusive, and culturally sensitive manner while also working
toward the goal of generating otopathology data that is more representative of the diverse U.S. population than
in the past. The proposed project is specific to bioethics research.

Public health relevance
Project Narrative Human temporal bone (ear histology) research is critical for advancing our understanding of the mechanisms of hearing and balance; however, the literature may not accurately represent the diverse U.S. population. We have an opportunity to improve the diversity of temporal bone research by using specimens from archival temporal bone collections from the 1900s and making these specimens available for study by other researchers, but we must first consider the ethical implications of using these archival collections for research. This study will systematically assess the history and ethics of human temporal bone donation in the 1900s and develop a system for ensuring feedback from community members.